C1 INHIBITOR IN PATIENTS WITH HEREDITARY ANGIONEUROTIC EDEMA

A patient with hereditary angioneurotic edema (C1-inhibitor deficiency) also has SLE and is secondarily deficient in C4. Patients with hereditary C4 deficiency are subject to severe SLE. She was given infusion of human C1-inhibitor to prevent the destruction of C4 in her serum by the uninhibited C1. This failed to induce a remission in SLE or to elescript submitted, and treatment with C1-inhibitor was stopped.